Integration of advanced imaging and multiOMICs to elucidate pro-atherogenic effects of endothelial-to-Immune cell-like transition (EndICLT)

Project Summary/Abstract
Atherosclerosis is a multifactorial disease accounting for a leading cause of morbidity and mortality. The
endothelium, the inner lining of vessel walls, transduces constant and rhythmic wall shear stress (WSS) from
blood viscosity and flow. At the medial wall of arterial bifurcation, stable unidirectional laminar flow (S-flow)
develops attenuates systemic inflammatory responses, whereas bidirectional and axially misaligned flow in the
lateral wall determine focal but eccentric nature of chronic low-grade inflammatory responses, endothelial cell
reprogramming and preferential formation of atherosclerotic lesion. Our unbiased scRNA seq and gene ontology
analysis suggested that D-flow induces endothelial-to-immune cell like-transition (EndICLT) and pro-atherogenic
pathways. However, the pathophysiological significance of EndICLT in vivo and whether it could serve as an
anti-atherogenic therapeutic target is yet remains elusive. One of the longstanding technical challenges is
interrogating cell signaling machinery and function simultaneously to unravel key mechanisms in action and
dynamic changes in pathophysiological milestones. Comprehensive insights into atherosclerosis and endothelial
dynamics can be achieved by visualizing multiomic atlas throughout the plaque. Cutting-edge fluorescence
microscopy in optically cleared plaque provides qualitative and quantitative evaluations of atherosclerosis.
However, current modalities of fluorescence imaging and time demanding procedures of conventional tissue
clearing techniques limits high throughput imaging with high spatial resolution. The advent of multi-scale sub-
voxel light-sheet fluorescence microscopy combined with a rapid clearing of plaques may address unmet
challenges. In this grant, we will use novel approaches of tissue clearing, advanced image acquisition to elucidate
flow-sensitive mechanisms, whereby EndICLT promotes atherosclerosis. In Aim1, we will examine whether the
novel dichloromethane - histodenz gradient medium clearing technique has potential for rapid extraction of
multiomic information in optically cleared plaque. Conventional fluorescence microscopy techniques including
wide-field and diffraction-limited confocal microscopy creates interference from out-of-focus illumination and
reduced axial penetration depth across the specimen. In Aim 2, we will focus on establishing an advanced
imaging platform of LSFM followed by sub-voxel reconstruction (SV-LSFM) and machine-learning based image
segmentation for scalable extraction of multiomic features in high spatial resolution. Finally, in Aim 3, we will
integrate Aim 1 and 2 to explore key underlying mechanisms in the EndICLT-dependent atherogenesis. Together,
these aims will allow a paradigm shift to identify novel therapeutic targets of atherosclerosis. This proposal will
allow me to deepen my research experiences and provide a critical support to build a strong foundation for a
career in cardiovascular research.

Public health relevance
Project Narrative: Disturbance in blood flow induces endothelial cell reprogramming via endothelial-to-immune cell like transition (EndICLT) and promotes atherosclerosis. Yet, flow-sensitive mechanisms, whereby EndICLT promotes atherosclerosis remains elusive. This study proposes a novel approach to uncover EndICLT and examine its therapeutic potential for atherosclerosis.